A Nanoelectronic Strategy for Reliable Chronic Neural Recording

The ability to reliably detect and track individual neurons with sufficient temporal resolution in time scale
commensurate with learning and memory is critical to both basic and translational neurosciences. Chronically
implanted neural electrodes constitute the only means to electrically interact with living brains at sub-
millisecond time scale and single neuron resolution, but suffer from persistent interface degradation that leads
to substantial recording condition changes in both the short and long term. There is a growing awareness that
addressing the dimension and mechanical properties of the neural probe might improve the interface. However,
neural probes that provide reliable recording for extended periods with no chronic detrimental effects pose
stringent requirement on the robustness and bio-compatibility of the device, which are yet to be developed.
The overall objective of this project is to achieve stable tissue-probe interface and reliable electrical recording
by developing, testing and optimizing nanoelectronic thread (NET) neural probes. This will be studied by
extensive in vitro characterization and in vivo in rodent models (mouse and rat) where the tissue-probe
interface and the neural probe recording conditions will be monitored and evaluated over chronical implantation
durations. Repeated in vivo imaging of the cellular and vascular evolution near the implanted probes will be
used together with postmortem histology studies and comprehensive characterization of the chronical
recording performance to assess and optimize the functionality of NET probes. The central hypothesis of the
project, on the basis of strong preliminary data from the applicant's laboratory, is that chronically reliable
electrical recording with non-degrading tissue-probe interface can be achieved by matching the neural probe
physical properties, in particular the dimensions, the surgical footprint and the mechanical flexibility, with that of
the cellular networks in living brain. The specific aims are to test this hypothesis: 1) Design and optimize NET
probes for long-term in-vivo structural stability; 2) Evaluate and optimize the long-term biocompatibility of the
NET probes; and 3) Verify and optimize long-term reliable recording and tracking of individual neurons. The
approach is innovative, in the applicants' opinion, because it represents a new and substantive departure from
the status quo by focusing on the aggressive reduction of the dimension and rigidity of the neural recording
devices into previously unattainable regimes. The long-term goal of this project is to identify key design
parameters that enable chronically stable integration between man-made devices and living brain tissue so
that these parameters can be applied to guide the design of a variety of neural implants for advancing
fundamental neuroscience and benefitting neurological condition treatments. The unprecedented chronic
reliability and stability in electrical recording expected to be achieved in this project will also lead to substantial
improvement in the brain-machine interface that can be applied to neuroprosthetics.

Public health relevance
The proposed research is relevant to public health because the development of minimally invasive neural electrical probe is ultimately expected to advance both the understanding of neural circuitry and the treatment of neurological conditions by providing chronically stable brain-electronics interface. Thus, the proposed research is relevant to the part of NIH's mission that pertains to the development of new biomedical techniques and devices that will improve the understanding, treatment, and prevention of disease.